DOES DEHYDROEPIANDROSTERONE AFFECT PSYCHOMOTOR RESPONSE TO ALPRAZOLAM

The administration of dehydroepiandrosterone (DHEA) decreases psychomotor decrement after alprazolam administration. The proposed research is designated to delineate the potential role of DHEA as a predictor of response to benzodiazepines. This has potential value to predict a decrease in the risk:benefit ratio for benzodiazepine use in the treatment of anxiety and insomnia in the elderly.